Weill Cornell/Rockefeller/Sloan-kettering MST Program

DESCRIPTION (provided by applicant): The Tri-lnstitutional MD-PhD Program is a joint undertaking of Weill Cornell Medical College (WCMC), The Rockefeller University (RU), and the Sloan-Kettering Institute for Cancer Research (SKI). Its mission is to train biomedical investigators who: on the one hand, have advanced understanding of biomedical science and a mastery of contemporary research skills, which will allow them to undertake fundamental studies to elucidate basic biological processes pertaining to human disease;and, on the other hand, are well grounded in human biology, pathobiology and clinical medicine, which will equip them to transfer advances in basic research to the understanding, prevention, and treatment of human disease. The three institutions operate three graduate schools: Weill Cornell Graduate School of Medical Sciences (WGS), a joint undertaking between WCMC and SKI;the David Rockefeller Graduate School at RU;and the Gerstner Graduate School of Biomedical Sciences (GSK) at SKI. The Tri-lnstitutional MD-PhD Program was formed in 1991, when two independent MD-PhD Programs, the WCMC-RU Program and the WCMC-WGS Program, were joined to form the present program. GSK will become part of the Program on July 1, 2009. MSTP trainees complete all the requirements for the MD degree at WMC. They will get their PhD training in research laboratories in three research institutions and receive their PhD degree from GSK, RU or WGS. Accepted trainees arrive in early July before the start of medical school. During the first two years in the Program they complete their medical school course, take two graduate level courses designed for MD-PhD students, and complete three research rotations (in three different laboratories) before they settle into their thesis laboratory. When the students choose a research laboratory they enroll in the graduate school with which their thesis mentor is associated. The graduate course and thesis requirements are similar for all MD/PhD students, irrespective of the graduate school in which they are matriculated-and the students can cross register and take courses for credit in any of the graduate schools. At the end of their research training, after they have defended their thesis, the students return to complete their clinical training at WMC. The present application requests funds to continue MD-PhD training at the three institutions beyond Year 35 (the predecessor WMC-RU Program was formed in 1972;it received NIH funding in 1974). In its current iteration, the Program brings together faculty in more than 270 independent research laboratories. More than 250 MD-PhDs have graduated from the MD-PhD Program and its predecessors;currently there are 110 students in the Program. The current trainees come from 56 undergraduate schools. Their average GPA is 3.77, the combined MCAT score is 35.4. 95% of the graduates pursue post-graduate clinical training;of the graduates who have completed their training, 88% have appointments in medical schools, research institutes or biotech/pharma.